UCSD Research Training Program for Veterinarians

PROJECT SUMMARY/ABSTRACT
There is an existing need for talented veterinary scientists trained in basic and translational research who apply
the principles of “One Health” to discover the next generation of advances in medicine for the improvement of
health in humans. This application to renew an institutional T32 grant seeks funds to extend our efforts to build
an outstanding program for veterinarians to acquire the knowledge and skills in basic science, comparative
medicine and translational research in order to develop and apply models of human disease for the purpose of
improving human health. The specific goal of our Training Program is to nurture the development of DVM
investigators in the broad field of biomedical research with the expectation that these individuals will go on to
become independent investigators at academic institutions or industry. This will be achieved by pursing the
following Specific Aims: Aim 1: Identify a diverse and well-qualified pool of applicants from across the country;
Aim 2: Provide an inspiring didactic program that is tailored to each applicants learning agenda; Aim 3:
Acquaint trainees with the ongoing approaches for basic, computational and/or translational research related to
human disease; Aim 4: Mentor the trainees in the design, execution, evaluation and presentation of
experiments leading to original research and giving the trainees the skills required for independent careers in
academics. Through this program, trainees will gain knowledge and technical skills to fully understand and
evaluate the pathogenesis of disease in humans as well as animal models of human disease through both
didactic coursework and applied training in microbiology, immunology, computational studies and comparative
medicine. Trainees will be able to find mentorship from a successful group of scientists who are dedicated to
research training. The mentors/thesis advisors are comprised of experienced preceptors from basic and
translational research programs in microbiology, immunology, cancer, neurobiology, evolution, bioinformatics
and comparative medicine that include a cadre of veterinarians with an established record in post-graduate
training and mentorship of DVM graduates. Their research programs utilize collaborative and multi-disciplinary
approaches employing state-of-the-art techniques in cell biology, microbiology, immunology, systems biology,
bioinformatics and comparative pathology. By observing strong, interactive programs in multiple departments
at UCSD and throughout the research community in San Diego, the trainees will have an outstanding
opportunity to pursue an agenda for successful professional development. This training program will be
administered by faculty associated with the UCSD Center for Veterinary Sciences and Comparative Medicine.
As a result of this training program, trainees will gain a comprehensive understanding of hypothesis-based
research and gain knowledge and skills required for productive careers in academics that will address the
national needs for the development of skilled scientists in mouse pathobiology and comparative medicine
relevant to human health.

Public health relevance
PROJECT NARRATIVE There is an existing need for skilled veterinarians trained in basic and translational research to lead the next generation of advances in biomedical research that will improve human health. The existing program at UCSD serves as a core supporting other veterinarians committed to research through mentoring, didactic instruction and facilitating experiences to assist in their professional development. This application for an institutional T32 grant seeks funds to continue an outstanding program for veterinarians to acquire the knowledge and skills in basic science and comparative medicine in order to develop and apply models of human disease for the purpose of improving human health.